Cell sorting flow cytometer for BSL3 research

Project Summary
This shared instrument grant requests funds for a new flow cytometer, the Sony MA900, to be installed at
Yale University and dedicated to BSL3 research using fluorescence-based flow cytometry for either cell
sorting or purely analytic purposes. Flow Cytometry is a critical resource for biomedical research. Nearly
every discipline in the biologic sciences uses this technology that can be critical for a variety of
applications downstream of the sorting of cells based on phenotype. There is strong interest in studying
infectious disease at Yale – both at the cellular and host-response level. Many investigators performing
BSL3 research rely on a cell-sorting flow cytometer within the BSL3 facility to process infected cell
samples that can not undergo fixation. This is particularly important when cell sorting of unfixed infected
samples is required for subsequent in vitro cell culture assays or single cell RNA sequencing. Numerous
high-impact papers have resulted from prior BSL3 research at our institution, but many on-going studies
require continued access to reliable BSL3 flow cytometry. The requested equipment would replace an
aging BD FACSAria. The vendor will soon cease to offer service contracts on this model. Since this is the
only cell-sorting flow cytometer available for BSL3 researchers, any equipment breakdown could result in
delays that would significantly impede ongoing research. Thus, it is critical that this instrument be
replaced with a reliable cell-sorter that can be repaired in a timely fashion, preferably one that can be
operated independently by investigators when staff is not available.

Public health relevance
PROJECT NARRATIVE This shared instrument grant requests funds for a type of instrument that provides a rapid analysis of multiple characteristics of single cell suspensions. The requested instrument is a type of flow cytometer that can sort cell populations based on their expression of proteins that have been fluorescently tagged. It will be installed in a BSL3 facility where studies are performed on infectious pathogens that cause severe human disease. The requested equipment will empower researchers to enrich specific cell populations to use in subsequent assays in vitro or in vivo, providing critical insights into the function of cell subsets and their interactions in tissues infected with pathogenic viruses.